GROWTH HORMONE THERAPY OF CHILDREN WITH RENAL FAILURE

The general objective of this study is to determine whether growth hormone treatment of children with chronic renal failure rapidly increases the availability of serum IGF-I to IGF-I antibodies by increasing IGFBP-3 proteolysis.